Dissecting innate immune mechanisms of resistance to checkpoint blockade therapy in bladder cancer

PROJECT SUMMARY
Bladder cancer is the fifth most common cancer in the United States, accounting for around 47 deaths per day.
Promisingly, five PD-1/PD-L1 immune checkpoint blockade (ICB) therapies were approved for bladder cancer in
2016. Although these ICB treatments have achieved durable clinical responses in a subset of patients (15-25%),
the majority of patients have still not benefitted from this therapy. This clinical urgency to extend the benefits of
ICB to more patients has led to a need to investigate tumor intrinsic mechanisms underlying resistance. Tumor-
promoting inflammation, a hallmark of cancer pathogenesis, is known to contribute to cancer growth in multiple
ways including restraining antitumor immunity. We discovered a gene signature from pre-treatment tumor
associating with myeloid cells that is enriched in inflammation and innate immune genes and predictive of poor
ICB outcomes and survival in two ICB clinical trials. I plan to follow up on this work and dissect the innate immune
landscape of bladder cancer and investigate mechanisms of myeloid-cell mediated resistance to ICB therapy.
Aim 1 seeks to define the landscape of untreated bladder tumors and provide insight into the immune cell
subsets underlying ICB resistance. I will construct a transcriptomic and molecular atlas of bladder cancer at a
single-cell resolution, a resource that does not currently exist. I will build atlases of patients’ tumor, blood, and
urine using single-cell RNA sequencing, Cellular Indexing of Transcriptomes and Epitopes by Sequencing
(CITEseq), spatial transcriptomics, and O-link proteomics and analyze them using Seurat and other R-based
tools. I plan to resolve myeloid cells expressing this resistant gene signature and define their cellular interactions.
In Aim 2, I will delve into the transcriptional pathways in myeloid cells that are contributing to ICB resistance. We
have identified NLRP3 inflammasome activation and IL-1β signaling in tumor monocyte-macrophages (mono-
MΦs) as candidate pathways promoting tumor inflammation and progression. I will model these mono-MΦs by
differentiating peripheral blood monocytes into MΦ using GM-CSF and M-CSF under hypoxic conditions with IL-
1β and NLRP3 inflammasome activators., I will test effects on adaptive immunity by co-culturing these mono-
MΦs with activated autologous CD8+ T cells. I will also use this model to test drug candidates known to modulate
IL-1β and NLRP3 inflammasome activity as potential combinatorial treatments with ICB in bladder cancer.
This proposal combines direct ex vivo single cell genomics with in vitro functional experiments for a thorough
interrogation of the innate immune contribution to ICB resistance in bladder cancer. Combined, these aims will
elucidate innate immune pathway driven resistance to PD-1/PD-L1 ICB therapy in bladder cancer, which can be
used to identify critical predictive clinical biomarkers and inform new combinatorial treatment strategies.

Public health relevance
PROJECT NARRATIVE Although PD-1/PD-L1 immune checkpoint blockade (ICB) therapy has achieved durable clinical responses in a subset of bladder cancer patients (15-25%), the majority of patients have not benefitted from this therapy. These studies will build off our preliminary discovery of a pre-treatment myeloid-associated gene signature predictive of ICB resistance in bladder cancer by creating an immune atlas of treatment-naïve bladder cancer tumor, peripheral blood, and urine, a resource that does not currently exist, and establishing an in vitro monocyte- macrophage culture system to define and modulate the precise biological pathways and myeloid subsets underlying ICB resistance. Combined, these proposed aims will elucidate innate immune pathway driven resistance to ICB therapy in bladder cancer, which can be used to identify critical predictive clinical biomarkers and inform new combinatorial treatment strategies.